Stroke Connectome MRI biomarkers for VCID risk assessment

PROJECT SUMMARY
Vascular Contributions to Cognitive Impairments and Dementia (VCID) is one of the four Alzheimer’s Disease
and Related Dementias (ADRDs). VCID research investigates the effects of a range of vascular disease and
vascular risk factors on cognition. Every year 610,000 people in the US have first-time strokes and three-quarters
of strokes occur in people aged 65 and older. Post-stroke cognitive impairment and dementia is highly prevalent
(~30%) and is a major cause of adult disability in the US, with economic burden in the billions. Post-stroke
dementia is defined as an immediate and or delayed cognitive decline that begins within 6 months after a stroke.
Therefore, post-stroke cognitive impairments and dementia is recognized as a major VCID. However, the
underlying disease biology linked to stroke is not fully understood. There is robust evidence that AD pathology
often coexists with cerebrovascular disorders such as stroke, with many risk factors being shared, resulting in
additive or synergistic effects on cognitive decline. However, there is also a distinction made between ‘early-
onset post-stroke dementia’ which depends on the complex interplay between stroke and brain resilience, versus
‘late-onset post-stroke dementia’ which depends on severe small vessel disease, rather than by recurrent stroke
or concurrent AD pathology. However no biological biomarkers have yet been reported to reliably differentiate
between neurodegenerative and cerebrovascular disease. Understanding the relationships between the two
diseases therefore remains a high priority to enable targeting of underlying mechanisms and reducing the overall
burden of VCID. The specific goal of this project is to investigate the utility of blood-plasma based
phosphorylated-tau (p-tau) and apolipoprotein 𝜖𝜖-4 gene (APOE4) in predicting progression to post-stroke VCID.
p-tau represents the extent of amyloid burden in the brain and APOE4 is linked to risk for developing AD. Our
central hypothesis is that interactions between amyloid burden, APOE4 genetic risk, and stroke would better
explain the underlying pathology of why a subset of stroke patients go on to develop VCID. Specific Aim:
Characterize specific relationships between VCID risk factors, cognitive reserve, blood plasma biomarkers (p-
tau, APOE4), brain health and cognitive function at 6 and 12-months after stroke. Successful completion of the
project will provide currently lacking scientific understanding of the intricate biological relationships among VCID
risk factors, blood, and stroke MRI biomarkers, which underlie the biology of cognitive decline after a stroke.
Blood-based biomarker testing is more accessible, and less complex compared to PET scan or lumbar puncture
for assessing amyloid burden in the brain. Therefore, the proposed project is expected to exert a significant
influence on the field of molecular and genetic biomarkers of post stroke VCID. The results will lay a strong
foundation for building accurate diagnosis, prognosis, and future clinical studies that can aid in positively altering
disease progression and reducing the burden of illness on patients due to post stroke VCID.

Public health relevance
PROJECT NARRATIVE Every year more than 795,000 people in the United States have a stroke with currently around 4.7 million stroke survivors, and approximately 20% of the survivors go on to develop cognitive impairments and dementia later in life. This research project will seek an improved basic scientific understanding of the how the complex biological interactions between vascular, demographic (e.g., disadvantaged neighborhoods), and genetic risk factors, baseline brain and cognitive health, amyloid burden, and adaptive or maladaptive brain changes following an ischemic stroke, underlie the biology of vascular contributions to cognitive impairments and dementia (VCID). It will also seek development of diagnostic and prognostic tools based on non-invasive high-quality MRI and blood biomarkers which may aid in positively altering disease progression and reducing the burden of illness on patients due to post ischemic stroke VCID.